Leveraging Extensive Social Determinants Data and Spatial Data Science to Reduce HIV Incidence across the United States Ending the HIV Epidemic Counties

PROJECT SUMMARY/ABSTRACT
Geographic and racial/ethnic disparities in rates of HIV diagnosis and pre-exposure prophylaxis (PrEP) uptake
are wide and persist. The Ending the HIV Epidemic (EHE) initiative prioritizes targeting 57 jurisdictions including
7 states and 50 counties with the highest HIV rates in the United States (U.S.). To reduce disparities, precise
detection and forecast of new HIV diagnosis hotspots are required to accurately identify PrEP shortage areas to
inform optimal allocations of PrEP providers who can serve the population efficiently to reduce new infections.
This task relies highly on rigorous studies to examine contextual and structural factors such as community mental
health prevalence and other socio-structural environmental determinants that are likely critical to preventing new
HIV infections. Four inter-related contextual factors that address these gaps are: transportation-based
measures of PrEP accessibility, community mental health prevalence, social capital, and religious
institution environment in an area. We use spatial data science, cyberinfrastructure methodology, and
geospatial statistical analyses to develop novel indicators of these measures by mining data from several
sources including AIDS Vu, The American Community Survey, and other proprietary data sources to accomplish
the following: AIM 1: Create transportation-based measures of PrEP accessibility using Gaussian two-step
floating catchment area (G2SFCA) analysis, at the county and zip code levels, for both urban and rural transport
systems. AIM 2: Use Bayesian spatial analyses to quantify how the distribution of religious institutions
environment, social capital, community mental health prevalence, and transportation-based PrEP accessibility
are associated with: new and late HIV diagnoses rates, and with PrEP uptake at the county, and zip code levels.
AIM 3: Develop an interactive HIV data visualization Web tool to identify HIV hotspots and where to allocate
additional PrEP providers. The Web tool will also display which (and to what extent) socio-structural variables
drive HIV hotspots. We will evaluate the acceptability and feasibility of the tool through semi-structured interviews
with n = 20 stakeholders (e.g., HIV surveillance epidemiologists, community leaders, and people living with HIV).
Impact: Despite efficacious HIV prevention and care technologies for individuals, HIV-related disparities persist
by race/ethnicity across geography. Successful completion of this research can contribute to ongoing EHE efforts
to reduce 90% of new HIV infections by 2030. Moreover, the rigorous methods used in this project will contribute
to addressing the need for novel approaches for valid and reliable assessments, measures, and estimation of
structural factors that contribute to HIV in high-incidence populations. Our HIV data visualization Web tool is
novel because it facilitates identifying which determinants influence HIV the most and which areas are changing
in response to those variables, which in turn, may help researchers and practitioners identify the “right things, in
the right places, to curb the HIV epidemic.”

Public health relevance
PROJECT NARRATIVE The the determinants fundamentally visualization to burden of HIV and socio-structural risk and protective factors that drive HIV re not evenly distributed in United States and disparities i n HIV-related outcomes persist. Characterizing t he socio-structural t hat drive racial and geography-related HIV disparities in at the local and county-levels is important to addressing the patterns of HIV burden. Our project informs an HIV data Web platform that can enhance multisectoral approaches to respond to HIV at the population level reduce HIV related disparities. a